Component for Institution # 19-01414

This application is a competing renewal of the "Vervet Research Colony as a Biomedical Resource"
(VRC, P40-OD010965). The VRC is the only NIH-funded biomedical research resource for US-born
vervet/African green monkeys (AGM; Chlorocebus aethiops sabaeus) and has been continuously funded
since 2005. The VRC serves a wide range of local, regional and national investigators by providing
animals, biological samples, data, consultation and training pertaining to the use of vervets/AGMs
as multi-categorical, translational models of human disease. Since the previous renewal, the VRC
has provided resources to over 100 investigators, including over 250 animals and over 1,500
biological samples, as well as data and consultation. The VRC has also provided the necessary
infrastructure and technical expertise enabling the on-site use of over 600 animals across 30
different studies. The VRC has facilitated critical translational research across a wide variety of
disciplines, including: a) the development of the vervet as an emerging nonhuman primate model of
Alzheimer's disease risk with a focus on the assessment of amyloid burden, neurodegenerative
disease biomarkers, and synaptic degeneration; b) investigations into the efficacy and enhancement
of vaccines for infectious diseases such as neonatal influenza, respiratory syncytial virus, and
dengue fever; c) studies focused on the etiology and health consequences of diabetes, metabolic
disease and obesity; d) the development of novel, non-invasive biomedical imaging methodologies;
and e) the expansion of the critical genetic resources available for vervets, including the
sequencing of the vervet genome. The aims of the VRC resource are to: 1) provide the scientific
community with access to animals, biological samples, data and expertise to facilitate the use of
vervets for a wide-range of biomedical research; 2) to provide exceptional training opportunities
for veterinarians and researchers interested in using vervets for translational research, and to
serve as a platform for community and scientific outreach to foster better understanding of the use
of nonhuman primates in biomedical research; and 3) to enhance the resource by engaging in applied
research focused on continuing genetic and phenotypic characterization of vervets across the
lifespan and evaluation of the vervet as a potential translational model in novel research areas.
The VRC is a critical component of the Wake Forest Clinical and Translational Science Award (CTSA),
which provides administrative support and facilitates the utilization of the VRC resource across
the larger CTSA network. The VRC is able to take full advantage of a wide-range of existing
research facilities within the Wake Forest School of Medicine, including multi-modal imaging
capabilities, veterinary and pathology expertise, and genetic and analytic resources.

Public health relevance
The vervet/African green monkey (AGM) is a valuable nonhuman primate model for studies of aging and Alzheimer's disease, cardiometabolic disorders, infectious disease and vaccine development, neuroscience, and genetics. The Vervet Research Colony (VRC) is the only NIH-supported biomedical research resource dedicated to providing animals, biological samples, and data, as well as training and consultation on the use of vervets/AGMs for translational research. Continued genetic and phenotypic characterization of the vervet, along with the maintenance and expansion of the VRC data archive and biological sample repository are all critical for meeting the needs of the scientific community.